Base Contract HHSN261201500036I Title: Preclinical PREVENT Cancer Program: Preclinical Efficacy and Intermediate Endpoint Biomarkers; POP: 9/22/15 - 9/21/18.Task Order HHSN26100001 Title: Contract

The purpose of this Task Order is to hold an orientation/kickoff meeting to discuss Standard Operating Procedures (SOP) for all Contractors awarded an Indefinite Delivery, Indefinite Quantity (ID/IQ) contract for the PREVENT Preclinical Efficacy and Intermediate Endpoints Biomarkers acquisition.